Oligo-Vascular Crosstalk in the Developing Brain: Implications for White Matter Injury in Congenital Heart Disease

Project Summary
This supplement application to the parent grant R00NS117804 is to support Ms. Iris Farnum, a
postbaccalaureate research assistant in her first year of training. Iris will receive direct mentoring from me
(Manideep Chavali, PI) and will be co-mentored by Dr. Ben Emery. This supplement will enhance Iris's training,
enabling her to focus on her research and acquire the technical and professional skills necessary to become a
competitive graduate school applicant and earn a Ph.D. in neuroscience. The research training plan has two
main components. Firstly, Iris will develop technical expertise in skills such as single molecule fluorescent in situ
hybridization (smFISH), immunohistochemical analysis of human and rodent neonatal brain injury specimens
This will also encompass training in confocal microscopy, image acquisition, and data analysis. Secondly, she
will gain expertise in developmental neuroscience concepts as she characterizes the functional consequences
of hypoxic injury on oligodendroglial lineage cells and white matter maturation. For this purpose, she will also
receive training in molecular biology techniques, including protein isolation and expression analysis, RNA
isolation, and expression analysis. She will also become proficient in isolation and aseptic culture of primary
oligodendroglial and ex vivo cerebellar slice cultures techniques. Additionally, Iris will receive training in data
analysis, statistical methods, and effectively communicating research findings.

Public health relevance
Project Narrative The proposed study will investigate cellular and molecular mechanisms of brain injury resulting from Congenital heart disease (CHD). Experiments will focus on metabolic disruptions seen in oligodendrocytes in chronic hypoxemic conditions as seen in CHD and how they contribute to white matter maturation delay and injury.